TRANSFORMATIVE LIPID EXCHANGE APPROACHES TO STUDY MEMBRANE ORGANIZATION

We aim to understand biomembrane structure/function with the aid of a lab-achieved breakthrough in
control of membrane phospholipid and sphingolipid composition via cyclodextrin-catalyzed lipid
exchange. Lipid exchange is generally efficient (80-100%), and permits preparation of lipid vesicles
mimicking natural membranes closely in terms of lipid asymmetry, the difference in the lipid
composition in the inner and outer lipid monolayers (leaflets). The lab has now extended this method to
control lipid composition of plasma membrane outer leaflets in mammalian cells (without harming
them), and without disturbing membrane sterol. The method is being applied to solve long-standing
issues of membrane organization and function. We proposed in 1994 what remains the working model:
that membrane domains form in cells due to segregation of sphingolipid-cholesterol rich liquid ordered
(Lo) domains from unsaturated lipid rich liquid disordered domains. In the last grant period, using lipid
exchange to prepare asymmetric membranes, we found how lipid structure in each leaflet controls
when there is overall induction or suppression of Lo domains. With physiologically-relevant lipids, we
found that Lo domain formation is greatly enhanced by loss of lipid asymmetry, and confirmed this is
also true in natural plasma membrane vesicles. This is important because transient loss of lipid
asymmetry occurs during signal transduction. In the next grant period we propose to test the hypothesis
that Lo domain formation is induced by loss of lipid asymmetry in intact cells by using red blood cells,
which have a number of advantages including only a single membrane, known lipid asymmetry, known
methods to control lipid asymmetry in situ, and facile use for lipid exchange. We will then extend
studies to metabolically-active cells to see if loss of lipid asymmetry stabilizes Lo domains during
antibody-triggered signal transduction in immune RBL-2H3 cells, and defining the importance of Lo
domains by exchange using lipids that enhance or inhibit Lo domain formation. In the last grant period
we also used lipid exchange to show the ability to form Lo domains is necessary and sufficient for a
lipid to support insulin receptor function. We proposed the hypothesis that localization in Lo domain,
which are thick, decreases insulin receptor transmembrane helix tilt, activating autophosphorylation.
We will test this hypothesis by defining receptor domain localization before and after activation, and by
mutations that lengthen or shorten its transmembrane segment, to see if predicted activity changes are
observed. We also propose to test a novel competition assay for defining receptor domain localization.
Finally, we propose to extend lipid exchange to membrane enveloped viruses. A range of lipids will be
exchanged into the envelope of pseudovirus with SARS CoV-2 spike or VSV-G proteins to see how
viral lipids/domains modulate cellular uptake. These studies may help design of improved vaccines.

Public health relevance
We our applying our new approach to control the cellular composition of specialized fats called membrane lipids within the membrane shell that surrounds cells to understand how membrane lipids and proteins are organized to control membrane function. Studies concentrate on membrane protein receptors (including insulin receptor) that control the response of cells to their environment, and on viruses for which controlling lipids may alter their ability to enter cells and their immunogenicity. The studies may lead to new methods to control membrane protein function to ameliorate disease and optimize vaccines.